Measure striatal adenosine-dopamine receptors interactions: from molecule to behaviors

Project Summary / Abstract
Adenosine 2A receptors (A2AR) and dopamine D2 receptors (D2R) are G-protein coupled receptors (GPCRs)
that are highly colocalized in the striatum. A2AR and D2R form functional heterodimers that exert allosteric
antagonism on the other receptor. Based on ample in vitro and in vivo animal evidence, several hypotheses
have proposed the critical involvement of A2AR-D2R heterodimer in dopamine-associated disorders, such as
psychosis and schizophrenia. For example, a recent adenosine hypothesis of schizophrenia posts that a
reduced tonic level of adenosine control through A2AR-D2R heterodimers contributes to an elevated
dopaminergic function in schizophrenia. However, mechanistic studies investigating the role of A2AR-D2R
heterodimers in patients remain limited, primarily due to the scarcity of evidence demonstrating antagonistic
interactions between A2AR-D2R heterodimers in human subjects. To address these limitations, noninvasive
neuroimaging tools can potentially measure the dynamic interactions of A2AR-D2R heterodimers in vivo.
Hence, the proposed study aims to provide neuroimaging data to demonstrate the bilateral interactions
between A2AR and D2R in nonhuman primates using pharmacological challenges. Specifically, we will
administer a D2R antagonist (cold raclopride) or an A2AR antagonist (caffeine) to measure the drug-induced
changes of receptor binding at the A2AR and D2R, respectively, using [18F]MNI-444 and [11C]Raclopride PET.
These findings will provide quantitative results indicating the level of receptor occupancy required to modulate
the other receptor system. Furthermore, we aim to translate the imaging paradigm into human subjects to
investigate the impacts of modulating D2R by an A2AR antagonist (caffeine) on behaviors. We will use
[11C]Raclopride PET/fMRI to measure the simultaneous responses in D2/D3R binding and the reward learning
behaviors with and without oral caffeine. The successful execution of these experiments will not only
demonstrate the ability of PET/MRI to characterize receptor-receptor interactions in vivo but also provide
translational evidence supporting the functional existence of A2AR-D2R heterodimers in human subjects.
These findings will lay the foundation for future clinical research to test novel adenosine-based hypotheses in
psychiatric disorders.

Public health relevance
Project Narrative Preclinical evidence indicates that adenosine modulates dopaminergic neurotransmission by forming adenosine 2A receptor – dopamine D2 receptor heterodimers offering a potential therapeutic target for dopamine-related disorders, such as schizophrenia. This project aims to quantitatively measure adenosine- dopamine interactions in vivo using pharmacological challenges in nonhuman primates and behavioral tasks in human subjects with PET/MRI.